Ventral hippocampal encoding of anxiety representations is shaped by thalamic input.

Project Abstract
Almost one third of adult Americans suffer from an anxiety disorder, carrying an enormous personal,
societal, and financial burden. Difficulty advancing novel more effective treatments for anxiety disorders is
because they are complex circuit-based conditions, resulting from dysfunction in several distributed regions,
connections, and cell types that generate normal adaptive behavior. Thus, a fundamental understanding of
how neural circuits become disrupted to generate maladaptive behavior is crucial if we hope to generate
impactful treatments. Recent work has revealed the hippocampus (HPC), which has classically been
implicated in learning, for its role in encoding emotionally charged environments and generating appropriate
behavioral responses. More specifically, emerging evidence from our lab has identified HPC neurons in the
ventral pole that project to the hypothalamus encode anxiogenic environments and bidirectionally modulate
avoidance behavior. Yet how and which inputs are involved in the generation of anxiety-related representations
in the ventral HPC remain unknown. Using a whole-brain cell-type specific anatomical screen, we identified the
anterior portion of the paraventricular nucleus of the thalamus (PVT), an area implicated in the processing of
salient emotional stimuli, as a putative source of anxiety-related information to the HPC.
Here, I will use a combination of cutting-edge optical, pharmacological, and computational tools to
dissect and characterize the thalamic-hippocampal encoding of anxiogenic contexts and control of anxiety-
related behaviors. Experiments done here will provide the first studies to interrogate how HPC encodes
anxiogenic contexts and the thalamic contribution in classical tests of anxiety. All in all, this study will provide
crucial insight into how circuits generate excessive avoidance (i.e., anxiety-related behavior) for new
therapeutic interventions for anxiety-related disorders.
All proposed experiments are well established techniques in the lab and part of a globally prestigious
neuroscience community, including prominent leading experts of circuit function, at The University of California,
San Francisco. Consequently, I am poised and positioned in an ideal world-class environment for completing a
successful and impactful doctoral dissertation. Work described here is in line with my overall goal of studying
neural circuit control of affective behavior and will serve as a solid foundation for my future postdoctoral work.

Public health relevance
Project Narrative The research proposal described here endeavors toward ascertaining neural circuit mechanisms that govern essential adaptive behaviors for organismal survival. Employing the latest state of the art tools, we will characterize how an extrahippocampal network integrates environmental stimuli and interoceptive information to regulate approach-avoidance behavior. Evidence arising from this proposal will elucidate central neurobiological mechanisms crucial for anxiety-related behavior and identifying potential neuropsychiatric targets.